Activation of Nrf2 during embryonic development - mechanisms and consequences

Abstract
Early life stage exposures to toxicants can result in islet malformations, which may predispose individuals to
diabetes. The glutathione redox microenvironment plays fundamental roles in embryonic development and cell
signaling, perturbation of which can result in functional or structural alterations that only become apparent with
subsequent stress or age. Surprisingly little is known about how embryos respond to oxidative stress, or the
impact of toxicant exposures on pancreatic β-cell development. This project takes a multi-level approach using
state-of-the-art techniques to elucidate the complex pathophysiological mechanisms by which exposures to
Per-and-polyfluoroalkyl substances (PFAS) that cause oxidative stress derail islet development, and the
consequences for β-cell function. We test the central hypothesis that deviations from the GSH redox
microenvironment and aberrant activation of the transcription factor Nrf2- at the wrong place and the wrong
time- impair β-cell development and function. There are three overarching goals of this project: 1) to deepen
our understanding of the role of Nrf2 activation in embryonic β-cells and islet development; 2) ascertain the
impact of PFAS on insulin biosynthesis; and 3) identify β-cell fragility and bioindicators of later-life metabolic
impacts that can be translated to human health. We will use transgenic zebrafish, confocal microscopy and
immunofluorescence, redox proteomics and insulin misfolding assays, and cultured β-cells to investigate
exposures to two common PFAS (PFOS, PFHxS), and a legacy aqueous film-forming foam (AFFF). This work
will have a sustained and powerful impact on the fields of developmental toxicology, redox biology, and the
developmental origins of health and disease and provides critical advances towards developing science-based
PFAS guidelines, targets for clinical interventions, and public health policies.

Public health relevance
Project Narrative Individuals may be predisposed to metabolic diseases like Type 2 diabetes as a result of the early life environment. Embryonic toxicant exposures can cause redox stress, disrupt developmental signaling pathways, and result in subtle structural or functional alterations to the insulin producing pancreatic β-cells. This project will use cell culture and zebrafish to provide an understanding of how embryonic exposure to chemicals like per-and- polyfluoroalkyl substances (PFAS) can damage the developing pancreas and insulin production, identify later-life functional impacts, and potential targets for mitigation.